Promoting Health, Safety, and Recovery Training following Declared Disasters in 2022

Abstract
The Atlantic Center for Occupational health and Safety Training (Atlantic COHST, the
Center) will provide essential training and outreach in response to the 2022 declared
disasters in Puerto Rico. Utilizing a broad-based approach, the Atlantic COHST will
address health and safety training needs of worker populations in Puerto Rico, including
communities, volunteers, day laborers, migrant, and other vulnerable worker
populations. Using existing knowledge and understanding of worker safety and health,
personal protective equipment, and experience in training disaster workers, the Atlantic
COHST can quickly adapt to meet the needs of this population. Rutgers School of
Public Health and the Migrant Clinicians Network will participate in the project. Over the
course of two years, the Center will offer 28 courses, reaching 385 trainees, providing
2,405 contact hours of training.

Public health relevance
Project Narrative The Atlantic Center for Occupational Health and Safety Training will provide essential training and outreach training and outreach in response to the 2022 declared disasters in Puerto Rico. Through these training and outreach programs, our target populations will be better prepared to protect workers and community members from health and safety impacts of disasters.